Penn State Clinical and Translational Science Institute

Contact PD/PI: Sinoway, Lawrence Isaac
0
! '' - - %"'" % ' + ',% -"(' % " ' ',-"-.- 0 , (+& "' -( % + - -! "&) -
( "(& " % + , + ! (' ! %-! '' - - ! , %&(,- "%%"(' "' + , + ! 1) ' "-.+ , ' "-, (%% (
" "' ( ' '' - - %-! ,2,- & , +/ (.- &"%%"(' ) ()% "' % + %2 +.+ % + "(', ( '-+ %
'' - - ", -! ,- - 4, % ' + '- .'"/ +,"-2 + , + ! "',-"-.-"(' 0"-! ,-+(' .%-.+ ( "'- + ", ")%"' +2
- & , " ' ' ! %-! ,2,- & (&&"-- -( -! ) ()% ' (&&.'"-" , "' (.+ + ! / / %()
+(0"' (.-+ ! ' -0(+$ ' ) +-' +,!"), -( -- + .' +,- ' -! (&&.'"-" ,4 ' , + ,, ++" +, -(
)+ / '-"(' ' -+ -& '- ' - ,- '(/ % ))+( ! , -( ! %-! (' +', +(,, -! %" ,) ' ' -+ ',% -"(' %
,) -+.& , % +'"' (+ '"3 -"(' 0 )+ -" ('-"'.(., / %. -"(' ' - +"/ ' ","(' & $"' -(
!" / ('-"'.(., *. %"-2 "&)+(/ & '- .+ /","(' ", -( -! (+' +,-(' ( -!+(. !(.- '' - - '
% + "' / ' "' +.+ % $ 2 (&)(' '- ( (.+ /","(' ", -! - "'- + ", ")%"' +2 - &0(+$ ' +(
' & '- ( ,- $ !(% +, ", +"-" % -( ,. ,, .+ ,) " " "&, +
!# ) "./ . $ !$ ' ( ' '( &'%+! '( $ %##*$!). & ')$ '( 0"%% '
+ , + ! +, ' ,- %",! .'"*. ) +-' +,!"), +(,, ' 2(' '' - - 0"%% )"- %"3 (' / ,- ,(.+ ,
( ! %-! + % / '- - -( "' (+& '(/ % ))+( ! , -( ! %-! (' +', ' ,( " % ' '/"+('& '- % "&)%" -"(',
) +-" .% +%2 , -! 2 + % - -( (.+ +.+ % )().% -"(' 0"%% "'- + - +.+ % (&&.'"-2 ' & '- '
(%% (+ -"(' -!+(. ! (&&.'"-2 -"/"-" , (',.%- -"(' , +/" , 0(+$ (+ -+ "'"' ' )"%(- )+(# -,
!# '%#%) ) '%* !$$%+ )!%$ $ !$+ ()! )%' $) ' ' ( ' !$ ' ()'* )*' ) )
" ' ) ( &'%)% %" + "%&# $) $ ()* . %#&" )!%$ , !" $(*'!$ ( ! $)! ! '! %' $
' &'% * ! !"!). )+(/" , 1) ',"/ + , + ! ,.))(+- ' , +/" , -( (' . - + , + ! ' %"'" %
-+" %, -! - & - -! ' , ( -! (&&.'"-" , 0 , +/ 0"%% ).+,. -! ,- %",!& '- ( ' &" %"'" %
' (+& -" , , + ! "/","(' - -! ( ' )+(&(- "'- + -"(' 0"-! -! ,()!",-" - "' (+& -" , ) "%"-" ,
+(,, '' - - ! , (+-, 0"%% &)(0 + , " '-",-, +(,, -! '"/ +,"-2
!# )!+ ". ( ' ' (%*' ( $ -& ')!( ) '%* %"" %' )!%$ ,!) %) ' * ( $ )
%$(%')!*# + -"/ & & +, ( -! %"'" % ' + ',% -"(' % " ' 0 + (',(+-".&
0"%% "' + , (.+ "'- + -"(', ( .,"' (' . (%% (+ -"(', +& ' -( +.+ % (&&.'"-" ,
!# * ) $ , $ ' )!%$ % ") &'% ((!%$ "( $ ( %" '( $ #&%, ' ) # )%
%$ * ) *$ !$$%+ )!+ $ !$) ' !( !&"!$ '. ' ( ' ! ',-"-.- 0"%% -! ( % )("'- (+ -! -+ "'"'
( "/ +, ' 1) ' "' 0(+$ (+ ( , !(% +, ' )+( ,,"(' %, +(,, '' - - -!
(',(+-".& ' (.+ ' 0 ) +-' +,!"),
Project Summary/Abstract Page 219
Contact PD/PI: Sinoway, Lawrence Isaac

" !

Public health relevance
PROJECT NARRATIVE - OVERALL The Penn State Clinical and Translational Science Institute advances clinical and translational science to improve health and combat disease. It does this through collaboration and team science across scientific fields, an infrastructure of research excellence and data-driven decision-making, strong partnerships, and educational opportunities for a diverse and expanding clinical and translational science workforce. This project builds on the lnstitute's cross-university foundation and generates innovation, enables efficient research, educates the existing and next generation of scientists, and focuses on the health needs of rural communities.